Examining the Role of Allostatic Load and Neighborhood Disadvantage in Cognitive Function Trajectories among Midlife and Older Black Americans

Project Summary
Black Americans are twice as likely to develop Alzheimer’s disease (AD) than White Americans. The
biopsychosocial determinants of cognitive function, an early-stage component of the AD continuum, are less
understood in the Black population. Allostatic load (AL), an indicator of multisystem (e.g., nervous,
cardiovascular) physiological dysregulation driven by chronic psychosocial stress, may be one determinant of
poor cognitive function. The neighborhood is an emerging social determinant of cognitive function that may be
especially relevant for Black Americans given historical systems of socioeconomic and residential
disadvantage. Neighborhood disadvantage together with perceived neighborhood stressors may exacerbate
AL, to the detriment of cognitive function for midlife and older Black adults. The overall research objective is to
examine the relationship between AL and cognitive function and whether this association is impacted by both
neighborhood disadvantage [i.e., neighborhood socioeconomic status (SES) and Black-White segregation] and
perceived neighborhood stressors (i.e., high disorder and low social cohesion) within Black midlife and older
adults. Secondary, longitudinal data will come from the 2006-2016 waves of the Health and Retirement Study,
a nationally representative study of health among the midlife and older (>50 years of age) US adult population.
Specific aims for this project include: (Aim 1) testing the relationship between AL and cognitive function using
baseline linear regression and growth curve models; (Aim 2) examining the moderating roles of neighborhood
SES and Black-White segregation on the relationship between AL and cognitive function to predict baseline
cognitive function and change over time using cross-sectional linear regression models and growth curve
models; and (Aim 3) analyzing the association between AL, perceived neighborhood stressors, and cognitive
function in baseline linear models and growth curve models stratified by levels of (1) neighborhood SES and
(2) Black-White segregation. The positive impact of the proposed research will be an increased understanding
of complex, multifactorial social-environmental and biological determinants of cognitive function among Black
Americans. Furthermore, by mentoring underrepresented students at Xavier University of Louisiana I will
contribute to increasing diversity in the aging research pipeline and expanding my university’s population
health and aging research capacity.

Public health relevance
Project Narrative The proposed research is relevant to public health because it aims to understand processes contributing to high rates of Alzheimer’s disease and related dementias in Black Americans by examining how the neighborhood environment may interact with allostatic load, a biomarker of stress-related physiological dysregulation, to affect cognitive function among midlife and older Black adults. Therefore, this research can inform the design of interventions and policies to target social-environmental and biological risk factors related to adverse cognitive outcomes, including Alzheimer’s disease, specifically among Black Americans. Moreover, the proposed research is relevant to the missions of NIH and NIA of preventing and slowing the development of Alzheimer’s disease and related dementias as well as supporting quality of life among aging Americans.